Interactions between Trichuris and the gut microbiota

PROJECT SUMMARY
Parasitic nematodes colonize over a billion people worldwide and are associated with a range of maladies.
Among these parasites, the whipworm Trichuris trichiura is particularly difficult to manage with existing
medication that target adult worms due to drug resistance and frequency of reinfection. Following ingestion by
the host, Trichuris eggs hatch in the gastrointestinal tract where they mature into adulthood and produce eggs,
which are then deposited back into the environment in feces to perpetuate the cycle. As such, the entire time the
parasite inhabits the host is spent in the presence of a diverse community of bacteria that are part of the gut
microbiota. We and others have shown that colonization by Trichuris trichiura and the model parasite Trichuris
muris restructures intestinal bacterial communities in humans and mice, respectively. Consistent with
interactions between parasitic nematodes and the gut microbiota, bacteria are required for T. muris to complete
its life cycle in mice due to a role for bacteria in promoting egg hatching. The details of how the gut microbiota
mediate egg hatching and the reproductive fitness of Trichuris remain obscure.
In preliminary results, we identified bacteria that differentially affect T. muris egg hatching and established a
novel C. elegans screen to identify bacterial gene products that have a conserved role in the reproductive fitness
of free-living and parasitic nematodes. The main objective of this proposal is to identify mechanisms by which
bacteria mediate Trichuris egg hatching and affect subsequent colonization of the host. First, based on our
findings that T. muris and C. elegans share a requirement for an arginine-dependent byproduct of E. coli, we will
identify this metabolite and determine how it impacts host reproduction using the two nematode models. We will
specifically test the hypothesis that polyamines are the key arginine-dependent factors in this system. Then, we
will delve deeper into how bacteria-egg interactions mediate hatching by determining the role of chitinase
produced by the parasite and compare bacterial species that promote versus impede hatching. Lastly, we will
determine whether bacteria displaying superior egg-hatching activity enhance T. muris infection of mice, and
using a new assay we developed for T. trichiura, extend our observations to the human parasite. We believe
these innovative approaches will improve our understanding of how parasites have adapted to their host
environment, and ultimately reveal vulnerabilities in the Trichuris life cycle that can serve as therapeutic targets.

Public health relevance
PROJECT NARRATIVE Parasitic intestinal worms and gut bacteria have co-evolved with humans and other mammals. A better understanding of how worms and bacteria interact in the gut may lead to new ways of controlling worm infections and reducing disease.